Investigating Risk and Protective Factors for Repetitive Head Impact Exposure in Law Enforcement Cadets.

PROJECT SUMMARY
Law enforcement training and job duties can expose law enforcement cadets (LECs) to repetitive head impacts
(RHIs). During the training academy, LECs complete weeks of subject control technique training, including
defensive tactics training and boxing. These are designed to test the LEC’s critical thinking, train acute stress
management, and teach proper use of force under pressure. However, these RHIs have the potential to result
in mild traumatic brain injuries (mTBIs), which can lead to behavioral changes, impaired cognitive performance,
and alterations to neural structure and function. These types of training drills cannot be eliminated, despite
their potential for RHIs, as having defensive skills is a critical component of law enforcement job
performance. The goal of this project is to inform modifications in training schedules and injury mitigation
strategies within the training academy, and ultimately safeguard operational capability and career longevity of
LEOs by the following specific aims. Aim 1. To determine if male sex is a risk factor for higher HAE exposure in
LECs. Aim 2. To determine if greater neck strength is a protective factor for lower HAE exposure in LECs. Aim
3. To determine if better visual-motor function is a protective factor for lower HAE exposure in LECs. I will be
successful in completing the proposed research plan with the support and mentorship I will receive from my
mentorship team. Dr. Caccese (sponsor) will provide expertise in RHI monitoring and concussion research,
enhancing my understanding of best practices in this field. Dr. Jeffrey Wing (co-sponsor) will provide statistical
analysis and interpretation expertise, to further my understanding and application of concepts learned in didactic
statistical coursework. Dr. Di Stasi (co-sponsor), an excellent clinician-scientist with a successful track record in
securing research funding, will assist in both my clinical and scientific development to attain my long-term goal
of being a leading clinician-scientist in the concussion research field. She will provide guidance in how to translate
the results from this proposed research to intervention studies as I begin my career. Dr. Onate (co-sponsor) has
expertise in clinical treatment of tactical athletes and research, supporting the foundation of the proposed training
and research plan. He will also provide constructive feedback and education on my mentorship and leadership
skills. This training and research plan will be conducted at The Ohio State University (OSU), a world-class
research organization and a multifunctional hub of clinical and basic science research. I will have access to the
several centers under the umbrella of OSU, including the School of Health and Rehabilitation Sciences, the Sport
and Tactical Athlete Injury Resiliency Science Lab, the Chronic Brain Injury Program, and the Human
Performance Collaborative. As a result of my mentor’s participation in the above centers, I will have the support
that is integral to both my training and research plan, and my career development as a productive,
independent clinician-scientist.

Public health relevance
PROJECT NARRATIVE Law enforcement training can expose law enforcement cadets to repetitive head impacts (RHIs) and mild traumatic brain injuries (mTBIs). This study aims to identify risk and protective factors for RHI exposure. The findings of this project will lead to informed modifications in training schedules and injury mitigation strategies, and ultimately the safeguarding of operational capability and career longevity.